NRG Oncology Network Group Operations Center

NRG Administrative Core Abstract
The NRG Oncology (NRG) Administrative Core provides the leadership and infrastructure
necessary to support the largest portfolio of clinical trials among the adult groups in the NCI
National Clinical Trail Network (NCTN), a membership encompassing over 220 main member
sites – including nearly every Lead Academic Participating Site (LAPS) and a robust
contribution to the overall management and success of the NCTN. NRG utilizes a highly
successful multiple-PI model to provide remarkably capable leadership and scientific oversight,
dynamic committee leadership and mentoring, knowledgeable and experienced administrative
and operational leadership, and appropriate associated support. NRG, a group formed only four
years ago, has leveraged the strengths of its legacy groups to form an integrated, modern
clinical trials organization addressing specific populations within the NCTN. It is notable that
NRG remained highly productive in all realms even while navigating the merger of the three
legacy groups, a testament to the remarkable leadership of NRG and the thoughtful
organizational structure put into place. In addition to supporting its own goals, NRG is a highly
collaborative member of the NCTN. NRG co-led a number of trials with other groups,
championed sixteen studies from other groups, participated in numerous NCI-appointed
steering committees, workgroups, and task forces, and led the development of new remote
monitoring standards. NRG has the leadership and infrastructure in place to continue to support
the clinical trial and membership goals as well as continue to serve as engaged stakeholders in
the overall management and success of the NCTN.